Testing Effective Methods to Recruit Sexual and Gender Minority Cancer Patients for Cancer Studies

Abstract: Recently, NCI called for research to effectively study small or rare populations relevant to cancer
research. Sexual and gender minorities (SGM) are small populations at disproportionate risk for cancer and
are under-researched in cancer studies. This administrative supplement application, in response to MD-22-
032, seeks funding to address an important, unforeseen challenge in research on sexual and gender minority
cancer patients. The principal challenge common across SGM is to develop effective methods to identify and
recruit such patients and survivors into NCI cancer studies. In Aim 1 of our parent study, we will document, in
depth, SGM’s attitudes towards participating in NIH cancer research, identifying facilitators and barriers that
influence willingness to participate. We will also investigate any impact discrimination and poor cancer care
has on research participation. We will recruit cisgender SM men, cisgender SM women and gender minority
cancer patients (n=15 per group) and compare experiences within these small populations and between SGM
and a cisgender, heterosexual patient comparison group.
This approach will advance our understanding of why SGM may be missing or systematically excluded
from cancer studies. Recently, researchers have highlighted the limitations of collapsing gender minorities into
a single category. Gender nonbinary is a fast-growing identity label that represents persons who identify with a
gender different than (or not exclusively as) woman or man and who may or may not personally identify as
transgender (TG). As such, nonbinary patients may have different challenges in cancer treatment than TG
patients and deserve to be studied separately. Similarly, TG men and TG women are likely to have different
experiences of treatment. Aggregating these gender groups into one may mask important subgroup
differences. For this reason, we seek to expand our current study. Instead of collapsing gender minorities into
a single group, we will recruit and interview up to 15 TG men, 15 TG women, and 15 nonbinary patients (N=45
total) on both their experience of cancer treatment and on their attitudes towards participating in NIH cancer
research. Results from this formative research phase will inform how to treat gender minority data for our
quantitative study in Aim 3. Impact includes the first study of gender nonbinary cancer patients ever conducted.

Public health relevance
Narrative: Gender minorities are under-represented in NCI research; for example, there are no studies specific to gender nonbinary cancer patients, and transgender cancer research, in general, is often limited to single case reports. To address this critical gap and to respect differences within gender minorities, we will conduct the first research on how to recruit nonbinary cancer patient into cancer studies, and increase sample size so that transgender men, transgender women, and nonbinary cancer patients can be analyzed separately. Then, we will conduct in-depth interviews comparing each group’s experience on their experience of treatment, quality of life outcomes, and willingness to engage in NCI cancer research.